Pennington/Louisiana NORC - Supplement NOT-OD-21-089

PROJECT SUMMARY In 2018 the Pennington/Louisiana NORC (P30 DK072476-16) established a repository of human subjects' data and biospecimens of nutrition and obesity research. The repository includes data and biospecimens from 213 studies and 13,787 unique participants (68% women and 38% with obesity) funded by the National Institutes of Health, Department of Defense, United States Department of Agriculture, American Heart Association, American Diabetes Association and other government and non-profit organizations. In September 2020, an online portal was opened to allow people to independently search the cadre of available data. As we transition to increase usage, it is imperative that we align with the FAIR and TRUST principles and to ensure we can appropriately track usage, utility, and impact. We have developed a comprehensive but conservative one-year project in response to NOT-OD-21-089, to achieve these goals. The overarching objective of this administrative supplement is to improve upon the “FAIR”-ness and “TRUST”-worthiness of the Pennington/Louisiana NORC Biorepository and its online portal. In aim 1, we will improve “FAIR”-ness by adding existing data and increasing metadata and establishing metrics for tracking and usage. In aim 2, we will improve “TRUST”-worthiness by promoting and demonstrating the methods used for data collection. Finally, aim 3, will explore the possibility for certification. This unique repository provides unique data on nutrition and obesity which seeks to benefit researchers across the country for years to come.

Public health relevance
PROJECT NARRATIVE The aim of this administrative supplement to P30 DK072476-16 is to align the Pennington/Louisiana Nutrition Obesity Research Center Biorepository with “FAIR” (Fairness, Accessible, Interoperable, Reusable)-ness and “TRUST” (Transparency, Responsibility, User Community, Sustainability, Technology)-worthiness Principles of repositories and data sharing and to learn how to evaluate usage, utility, and impact.